Functional Multi-omics of Aging

Project Summary / Abstract
A group of principal investigators at the University of Minnesota seeks to renew our Training Program under the
new title “Functional Multi-omics of Aging” to support predoctoral and postdoctoral trainees. The goal of the
Training Program is to assist exceptional young scientists develop the intellectual and technical skills needed for
productive careers as biomedical researchers and educators in aging biology with a focus on training in -omics
technologies. The Training Program is in its 14th year of funding and has trained 23 pre- and 15 post-doctoral
trainees. Didactic training occurs through four T32-led courses covering fundamental biology that drives aging,
the Geroscience Hypothesis of Aging, emerging -omics technologies in aging research, and professional
development to prepare trainees for the next step in their scientific careers. Novel to this funding period, the
Training Program will interface with the newly established and continually expanding Institute on the Biology of
Aging and Metabolism (iBAM) at the University of Minnesota to further provide trainees experiential training in
the biology of aging and multi-omics through workshops, conferences, seminars, symposia, journal clubs, and a
visitorship program. Through iBAM, our institution has recruited internationally prominent researchers in aging
biology and with this explosion of energy and ideas, our training faculty has grown from 19 to 23, diversifying
rank, background, and departmental homes. Training faculty research focuses on the use of -omics technologies
to reveal the molecular details behind aging and they draw trainees from five graduate programs: Biochemistry,
Molecular Biology and Biophysics, Chemistry, Integrative Biology & Physiology, Neuroscience, and
Rehabilitation Science. New leadership of this T32 takes on an MPI structure to capture the breadth of needs
with Drs. Arriaga, Lowe, and Niedernhofer synergizing their expertise in graduate education, -omics technology,
aging research, and professional development. Our aging research is supported by outstanding genomics,
proteomics, and imaging cores at UMN equipped with state-of-the-art single cell and spatial transcriptomics and
proteomics platforms. These new developments have led to an even stronger Training Program as measured
by the publication records and research career success of past trainees as well as the funding and training
records of Training Program faculty. Together, the team of distinguished mentors, the extensive interdisciplinary
collaborations among faculty and trainees from multiple departments, the technological resources, and the
didactic and experiential training helps our trainees to shape successful careers in aging research.

Public health relevance
Currently, we are in a period of history where the number of individuals over the age of 65 is doubling, leading to an epidemic of chronic multi-morbidities of old age, and creating an urgent need to discover underlying mechanisms of aging biology that promote disease. “Functional Multi-omics of Aging” is a training program in basic and translational aging research for pre- and post-doctoral trainees addressing this need. The program's success over the last 14 years is documented by outstanding publications and successful careers in biomedical research of former trainees.